Integrated Health Sciences Facility Core

ABSTRACT-INTEGRATIVE HEALTH SCIENCES FACILITY CORE:
The Integrative Health Sciences Facility Core (IHSFC) of the Center for Human Health and the Environment
(CHHE) is the central interface between basic scientists, data scientists, epidemiologists, clinical researchers,
and public health practitioners. Its mission is to catalyze multidirectional translation of research between
diverse model systems, population-based studies, and community partners to advance understanding about
the effects of environmental exposures on human health and facilitate use of this information by affected
communities to improve public health. The intentional disciplinary diversity of the IHSFC leaders has
developed the Core into a highly effective resource for CHHE’s internationally renowned scientists who
leverage diverse models for environmental health science (EHS) research, bioinformaticists who integrate data
streams from across the health sciences, and epidemiologists and community engagement specialists who are
substantively involved in local communities and translating CHHE research to improve public health. The
IHSFC has been highly successful in its goal to establish key translational partnerships and resources and
facilitate new and impactful interdisciplinary research connections and community engagement initiatives.
Reflection on these successes revealed that a major factor in these connections was access to data science
resources for interpreting, linking, and communicating results from basic science experiments through human
studies and, ultimately, community engagement. Therefore, in the next funding cycle the previously separate
data science efforts have been expanded and integrated into a new IHSFC Environmental Data Science Group
(EDSG) that provides Center members clear access to significant data science capabilities. With expertise
drawn from the Bioinformatics Research Center and the NC State Libraries, the EDSG component of IHSFC
provides best-practices in data management, analysis, and sharing into all Center activities. Additionally, in the
next funding cycle the IHSFC will revise its key personnel to accommodate the addition of the EDSG, will
establish and extend key programmatic partnerships, and is creating new and enhancing existing resources at
NC State and partner institutions. These activities will promote new opportunities for multidirectional translation
between basic science, clinical research, and community organizations.